RFA-DP-23-002, Improving Outcomes and Reducing Disparities for Patients with Inflammatory Bowel Disease through Epidemiology, Enhanced Disease Management, Dissemination, and Education

PROJECT SUMMARY/ABSTRACT
Inflammatory bowel diseases (IBD), including Crohn’s disease (CD) and ulcerative colitis (UC), are chronic,
relapsing and debilitating disorders without a cure. IBD affects more than 3 million individuals in the United
States, including people of all ages, sex, race and socioeconomic status. There is a critical need to better
define the role of social determinants of health on the course of IBD and to identify ways to mitigate health
disparities. The overarching goals of this research program are to improve quality of life and reduce health
disparities through: 1) rigorous epidemiological research to evaluate impact of social risk factors on the natural
history of IBD, 2) testing the effectiveness of innovative IBD management strategies to improve health equity
and outcomes, and 3) developing and evaluating stakeholder-informed patient and provider education and
awareness programs.
The project will consist of a 52-week, pragmatic, multi-center, open-label, randomized clinical trial with a
prospective cohort study embedded within the trial. We will include 1200 children (13-17y) and adults (>17y)
with IBD at 6 pediatric and 5 adult sites. Aim 1 is a prospective cohort study (n=800) that will be comprised of
participants assigned to the usual care arm of the pragmatic trial. The aim is to evaluate the association
between social risk and natural history and outcomes of IBD in children and adults,
Aim 2 will involve the development of a multi-stakeholder informed, tailored digital health intervention to
improve IBD management and patient activation followed by a pragmatic trial to compare the effectiveness of
the intervention versus usual care.
Aim 3 will address health disparities and increase IBD awareness through provider and patient education and
the dissemination of study findings and other evidence-based practices to researchers, clinicians, and patients.
This work will bring together a coalition of professional organizations, medical education events, disease-
associated non-profits and grassroot patient advocacy groups representing diverse patients with IBD who are
to create, conduct and evaluate live, in-person and digital education and awareness programs.

Public health relevance
PROJECT NARRATIVE This research will 1) comprehensively evaluate the independent impact of social risk factors on the natural history and outcomes of Inflammatory Bowel Disease (IBD) through a prospective epidemiological study and 2) develop a stakeholder-informed, scalable digital health intervention to enhance IBD management and evaluate its effectiveness in improving patient activation and clinical outcomes and reducing disparities through a pragmatic clinical trial. This project also seeks to translate these findings and other evidence into practice through robust patient and professional education, outreach and awareness programs. Taken together, this work will help to better understand and mitigate health disparities in the treatment of IBD, significantly improving clinical outcomes, quality of life, and health equity and directly informing healthcare policy and clinical practice.